Cognitive Domains Classification Using fNIRS-EEG

Abstract. Functional near-infrared spectroscopy (fNIRS) is a neuroimaging technique that uses low-levels of
light (650-900 nm) to noninvasively measure changes in cerebral blood volume and oxygenation. Meanwhile,
electroencephalography (EEG) measures the neural oscillatory activity which can be divided into various
rhythms frequency bands. We propose a paradigm shifting analysis approach where instead of using EEG or
fNIRS to estimate and test the de novo brain activation pattern for a specific task, we utilize our existing
knowledge of common patterns of brain activity from similar tasks done in fMRI to create a set of testable [null]
hypotheses; namely, “is the pattern of fNIRS/EEG measured [not] consistent with what is expected from (e.g.)
the general category of working memory tasks?”
Our innovative proposal is to map brain signals onto the “cognitive domains” underlying complex brain
functions rather than task themselves. Specifically, we purpose to use a projection (reparameterization) of
brain signals using spatial maps defined by the six key cognitive domains defined by the DSM-V; language,
perceptual-motor, executive function, complex attention, social cognition, and learning and memory. These
maps are generated from meta-analysis of hundreds of existing fMRI studies pooled across all tasks related to
the cognitive domain as a keyword allowing us to develop model training from a large repository of varied
tasks. This reparameterization and compression of the brain signals into this low dimensional space provides a
task-agnostic, statistically testable, and interpretable signal, which can be examined in real-time. The main
aims of this study are:
· Aim 1. Develop and validate fNIRS-EEG features in cognitive domains.
· Aim 2. Test-retest reliability of fNIRS-EEG features.
· Aim 3. Quantitative sensitivity-specificity report of the prediction model.
· Aim 4. Implementation real-time fNIRS-EEG for cognitive domain classification.

Public health relevance
Narrative Near-infrared spectroscopy (NIRS) measures cerebral blood oxygenation using light emitters and sensors placed on the surface of the scalp. Meanwhile, electroencephalography (EEG) measures electrophysiological brain activation created when neurons in the brain are firing. Those techniques are portable, low-cost, and versatile technology that is well suited for real-time detection of brain activity and brain computer interface (BCI) applications, however, neither is without limitations. In this Trail Blazer R21 proposal, we propose a novel approach in which instead of estimating the patterns of brain activity de novo for a task, we use brain activity patterns derived from meta-analysis of existing fMRI databases to construct a novel data compression model allowing us to implement a real-time, task agnostic, projection of fNIRS-EEG onto a low dimensional parameter space associated with each of the six key cognitive domains defined in the recent DSM-V.